Controlling Arbovirus Transmission: PopulationSuppression and Virus-Induced Mosquito Death

Abstract:
Aedes mosquitoes continue to transmit viruses such as dengue, Zika and yellow fever, with much of the world’s
population at risk. This is particularly true in Brazil, where dengue epidemics are continuous, where the Zika
epidemic hit hardest, and where urban yellow fever continually threatens to re-emerge. In order to establish new
vector control strategies, Brazil has pioneered the testing and approval of a new strategy called Release of
Insects with Dominant Lethality (RIDL), based on the intellectual property of Oxitec, LLC. RIDL relies on the
mass release of male Ae. aegypti mosquitoes; mating with wild females results in progeny that die as late larvae
or pupae. While field trials have demonstrated successful population suppression, obstacles to the widespread
use of the technology include difficulty in monitoring, competitiveness of released males, cost of antibiotic used
to suppress the lethal phenotype at factory scale, and rapid recovery of the mosquito population once releases
cease. Modeling suggests that the release of pathogen-resistant mosquitoes following a population suppression
campaign can result in the establishment of the resistance phenotype, a so called “reduce and replace” approach
that could more permanently block transmission. To develop a reduce and replace system for the control of
dengue/Zika transmission, a transgenic conditional sterility system in Ae. aegypti will be established (Aim 1).
Unlike current approaches where factory-scale rearing of released males must occur in the presence of
tetracycline, such an approach necessitates antibiotic use only in the egg production colony, substantially
reducing costs. Early embryonic lethality will in turn simplify monitoring approaches. This project will also develop
a death-upon-infection strain of Ae. aegypti that will provide broad resistance across all mosquito-borne
flaviviruses (Aim 2). This innovative approach takes advantage of progress already made in navigating
transgenic Ae. aegypti through the regulatory process in Brazil, and the products to be developed are anticipated
to directly enter the risk assessment process for field-based testing at the conclusion of this work.

Public health relevance
Aedes aegypti is the main vector of dengue, yellow fever and Zika viruses in both Brazil and the U.S., with recent outbreaks of local transmission in Texas and Florida. The release of sterile mosquitoes can potentially suppress vector populations, but current approaches are not ideal. Our proposal seeks to develop an improved conditional sterility system in the dengue mosquito for use in public health vector control programs, in both Brazil and the U.S.